Core B-Program Development

Project Description (Core B): The overall aim of PARC's Core B on Program Development / Pilot Projects is
to leverage innovations through PARC's new institutional structure (Core O), PARC's expanded, rejuvenated
and increasingly multidisciplinary set of PARC Associates, and innovative new data resources created by Core
D and PARC's research networks, in order to: Specific Aim 1: (i) Encourage new research in population aging
that reflects PARC’s expanded vision, stimulates new interdisciplinary collaborations at the intersection of
PARC’s Themes and Research Networks, and utilizes the new research opportunities created by PARC’s in-
vestments in Data Resource Development, (ii) enhance the training, research and career of junior scholars
and/or scholars new to research in the demography and economics of aging, and (iii) stimulate novel PARC pilot
projects addressing the significant and policy-relevant knowledge gaps in domestic and global aging research
outlined in the Significance of the Overall Core. Specific Aim 2: Explore and evaluate the feasibility of expanding
the list of sponsors of the annual QUARTET Pilot Project competition to include other NIA Centers at Penn.

Public health relevance
Project Narrative/Public Health Relevance (Core B): Interdisciplinary, co-operative research to advance knowledge in the demography and economics of aging requires an adaptive scientific infrastructure. The Popu- lation Aging Studies Center at the University of Pennsylvania, along with this Core B, provides an intellectual platform at the crucial juncture of the behavioral, social, and health sciences. The accounting and analytic frame- works of PARC, anchored in demography and health economics, provides insights to help meet the research and evidence needs to promote successful and equitable aging for individuals, and to inform effective health policy responses in aging societies, in the U.S. as well as globally.